Bronx Environmental Health Summer Training for Justice

Project Summary
We seek to develop the Bronx Environmental Health Summer Training for Justice (BestJustice) program for
high school students in environmental justice communities in the Bronx and Manhattan in New York City.
These communities not only experience some of the highest air and noise pollution levels in New York City
but are also less likely to have members of their community pursue higher education, which in turn contributes
to their continued marginalization and disinvestment. The BestJustice program expands the scope of an
existing Science Technology Engineering and Math (STEM) initiative between a public South Bronx high
school (X223), the Center for Environmental Health and Justice in Northern Manhattan at Columbia
University, and South Bronx Unite (SBU), a local non-profit grassroot organization. In this partnership, we
introduced a year-long STEM course, in which students received hands-on training to build air pollution and
noise monitors to then deploy them in the South Bronx through a citizen science after school program at
X223. Following a suggestion of X223, we compensated a small group of students for their effort by accepting
them at no cost into Columbia University’s Summer High School Academic Program for Engineers (SHAPE),
a 3-week long STEM summer program for high school students.
To sustain and expand this partnership and the educational opportunities for the students, the
BestJustice program seeks to formalize these efforts through a structured, on-site summer environmental
health science (EHS) research program. Each year, a group of students (n=12) will receive training that
prepares them for a career in EHS and allows them to conduct research that incorporates environmental
justice principles. Our goals are the following: 1) Provide accessible, locally relevant summer research
experiences in EHS. For eight weeks during the summer, the students will a) participate in the SHAPE
program through project-based courses in engineering that are relevant to biomedical and health sciences,
b) obtain environmental justice training, and c) conduct locally relevant EHS research mentored by Columbia
University faculty and graduate students, South Bronx Unite staff, and high school teachers. 2) Provide
training in scientific writing, communication, and research translation, including presentations to local
communities and to their high school science class and/or school. 3) Provide students with the skills needed
to create competitive applications for admission into undergraduate programs or technical schools, especially
fields relevant for EHS/STEM, and to provide guidance throughout this process to ensure their success.
The proposed BestJustice program, building upon a 3-year-old STEM initiative between Columbia
University, our partnering school X223, and South Bronx Unite, will have a high chance of increasing the
number of local students from marginalized backgrounds that pursue careers in EHS and other STEM fields.

Public health relevance
Project Narrative The proposed Bronx Environmental Health Summer Training (BEAST) program will expand the scope of an existing STEM initiative between a public high school in the South Bronx and Columbia University, by developing a structured, on-site summer research program for students from a public high school serving several communities in New York City. Through BEAST, each year, 12 student trainees will enroll into an 8-week long, on-site summer research program that will include 1) participating in the Columbia University engineering program, 2) obtaining environmental health training, and 3) conducting locally relevant environmental health research mentored by Columbia University Mailman School of Public Health faculty and graduate students, and high school science teachers. Additional college preparation modules will position the trainees well to apply for and pursue a college degree in environmental health sciences or other STEM fields.